Next Generation Immunotherapies for Pediatric Cancers

PROJECT SUMMARY
Since the 1990s, pediatric oncology has made sustained strides in understanding the biology that drives
children’s cancers, but these understandings have not yielded significant therapeutic gains. Approximately 20%
of children diagnosed with cancer today are not cured with current standard regimens and cancer remains the
leading cause of disease related death in children in the US and other high-income countries. Nearly all current
standard treatments are cytotoxic regimens, which are associated with shortened lifespans, high rates of severe
late effects and second malignancies and diminished quality of life. There is an urgent need to develop safer and
more effective, targeted therapeutics for treatment of children’s cancers. During the last three decades, the
Mackall lab has made sustained contributions to a growing body of evidence demonstrating that
immunotherapies can selectively target even the most aggressive cancers, raising the prospect that
immunotherapies specifically designed for children’s cancers could improve cure rates and diminish toxicity.
This program will build upon deep understandings of fundamental cellular and molecular immunology in the
Mackall lab and recent progress in defining mechanisms of immune evasion and resistance to current
immunotherapies to create next generation immunotherapies for children’s cancer that manifest enhanced safety
and potency and potentially enhance access to patients. We will leverage a surfeit of emerging synthetic biology
and protein engineering platforms emanating from scientific labs at Stanford University which have been, and
continue to be, integrated into the Mackall laboratory. This work will occur within the enabling ecosystem
provided by the Stanford Center for Cancer Cell Therapy, which is led by the PI and supports infrastructure to
enable rapid forward and reverse translation of promising therapeutics. Areas of focus will include, but are not
limited to, developing new approaches to overcome the suppressive tumor microenvironment in pediatric solid
tumors, optimizing multi-specific CAR T cells, using combinatorial engineering to create uber potent T cells while
enhancing understanding of toxicities that may limit application of these enhancements. We also will enter the
promising new arena of in vivo gene delivery to engineer immune populations without the need for cumbersome
and expensive ex vivo manufacturing. We have already demonstrated expertise in utilizing CRISPR/Cas9 for
screens and therapeutic manipulation and are routinely employing synthetic biology technologies including
CRISPR/Cas13 to regulate RNA, base editing to knockout genes without double strand breaks, mutagenesis
combined with yeast display to create proteins with unique and specific properties, drug regulatable platforms to
control protein expression and viral free cell engineering. Biopharma does not prioritize development of
therapeutics for children’s cancers, and thus this Program addresses a critical unmet need to leverage the latest
advances to develop more effective and less toxic immunotherapies for children’s cancers.

Public health relevance
PROJECT NARRATIVE This proposal is relevant to US public health since cancer remains the leading cause of disease related death in childhood in the US. In addition, while approximately 80% of patients diagnosed with cancer today will be cured of their original disease, few of these survivors will have a normal lifespan and most will experience secondary diseases and disabilities as a result of the toxic cancer therapies they receive. The proposed research is highly relevant to the NIH mission, as it seeks to discover new scientific principles and develop new immunotherapies for the treatment of children’s cancers, which will also provide generalizable knowledge regarding optimal approaches to develop immunotherapies for low mutational burden cancers occurring in other populations.